DLK1 regulates HSC quiescence through phase separation mediated inhibition of receptor signaling

Project Summary: While much is known about factors that stimulate the proliferation and differentiation of stem
cells, less is known about the factors that prevent their differentiation and preserve their function. One factor
implicated in the maintenance of an undifferentiated stem cell state is the non-canoncial Notch ligand, Delta like
homologue 1 (DLK1). DLK1 is widely expressed during embryogenesis where it regulates stem cells to control
organ size. In the adult, DLK1 expression is limited to select tissues, including hematopoietic stem cells (HSC),
where it has been shown to enhance the generation of primitive murine hematopoietic precursors. Yet, the
precise effects of DLK1 on stem cell proliferation and differentiation remain elusive.
In preliminary experiments using cord blood CD34+ cells, we have found that DLK1 knockdown decreased CD34+
precursors following in vitro culture and reduced their engraftment in immune deficient mice. In contrast, DLK1
overexpression led to an increased proportion of the least mature CD34+CD90lo precursors in vitro and an
increased proportion of CD34+ cells in vivo. Moreover, exposure of CD34+ cells to exogenous DLK1 extracellular
domain (ECD) increased longer-term engraftment. Using scRNAseq, we observed that DLK1 knockdown in
highly enriched HSC shifted the transcriptional state from a quiescent HSC (qHSC) to an activated HSC (aHSC)
during short-term culture. These findings compel further assessment of DLK1 effects on HSC quiescence in EC
co-culture, where previous studies have shown expansion of repopulating cells and preliminary studies suggest
the expansion of transcriptionally-defined qHSC following cell division in vitro. However, the mechanism by which
DLK1 elicits these effects is unclear. DLK1, an intrinsically disordered protein, has been reported to inhibit
multiple receptor mediated cell signaling pathways activated by extracellular ligand, including the TGFb, FGF,
Notch, and insulin pathways, each relevant to hematopoietic stem cell function. In preliminary studies using the
TGFb and Notch pathways as models, we have shown that DLK1 inhibits receptor activation via its ECD.
Additional studies suggest that ECD phase separation induces clusters in the plasma membrane, termed
condensates, that co-localize with TGFb and Notch receptor components, leading to altered receptor dynamics.
Herein, we test our hypothesis that DLK1 regulates HSC quiescence by elucidating: whether DLK1 maintains
and/or expands qHSC by inducing aHSC to return to quiescence (Aim 1); how DLK1 interactions with receptor
components within condensates alters receptor signaling (Aim 2); and whether inhibition of multiple signaling
pathways is required for the effects of DLK1 on HSC (Aim 3).
If successful, these findings will suggest that DLK1 maintains qHSC by inhibiting the ability of receptors to
respond to multiple environmental signals that induce HSC proliferation and differentiation through the alteration
of receptor dynamics within DLK1 condensates. These findings will provide the foundation for novel strategies
to enhance stem cell engineering, including the expansion of true repopulating HSC for transplantation.

Public health relevance
PROJECT NARRATIVE The hematopoietic stem cell is responsible for giving rise to all blood cells throughout the lifetime of an organism. Our goal is to understand one of the factors that control the decision for the hematopoietic stem cell to remain in a state of inactivity or differentiate into different blood cells. If successful, our studies will set the stage for the development of strategies to expand stem cells for various therapeutic purposes.